Metastatic Bone Disease and IL-6 as Drivers of Cachexia in Kidney Cancer

PROJECT SUMMARY
This proposal describes a five-year plan to develop Christopher Collier, MD into an independent orthopaedic-
surgeon scientist whose career goal is to drive bench-to-bedside research that addresses the musculoskeletal
effects of cancer. His prior education, research experience, and expertise in orthopaedic oncology prepare him
for this opportunity. This career development award will catalyze his growth by providing complementary training
in musculoskeletal biology, with an emphasis on muscle and bone biology, cancer cachexia, and laboratory
leadership. Dr. Collier will receive exceptional mentorship and instruction at the Indiana University School of
Medicine, an institution with a world-class environment for the study of musculoskeletal health and cancer. He
will also benefit from strong institutional support, including independent laboratory space and protected research
time, to enact his research plan. Cachexia is a syndrome of systemic muscle wasting and bone loss that is
responsible for 20 to 40% of cancer-related deaths. Recent evidence suggests a direct link between cachexia
and metastatic bone disease. The objective of this proposal, which addresses a critical need, is to define the
contribution of metastatic bone disease to cachexia in kidney cancer and identify key mediators. Kidney cancer
was selected because metastatic bone disease and cachexia are common disease features. Dr. Collier has
established a mouse model of metastatic kidney cancer to bone, which develops cachexia and elevated serum
IL-6. He hypothesizes that metastatic bone disease in kidney cancer increases systemic muscle wasting and
bone loss by IL-6 mediated activation of JAK/STAT3 signaling in muscle. This hypothesis will be tested by
pursuing three specific aims. Aim 1 will determine the impact of metastatic bone disease on cachexia in kidney
cancer in vivo. Tumor cells will be implanted into mouse kidney, lung, or bone and cachexia outcomes compared.
Aim 2 will determine the drivers of IL-6 signaling in kidney cancer and the potential of IL-6 blockade to reduce
cachexia. IL-6 levels in serum and JAK/STAT3 signaling in muscle will be measured in tissues from Aim 1. IL-6
will also be deleted and/or pharmacologically neutralized in mice to determine the effect on cachexia. Finally,
Aim 3 will establish the contribution of metastatic bone disease to cachexia and the IL-6 pathway in kidney cancer
patients. Human serum and muscle will be collected from patients with localized kidney tumors or metastatic
bone disease and compared. Collectively, these studies will describe the impact of metastatic bone disease and
IL-6 on cachexia in kidney cancer. This research is conceptually innovative because it is the first to investigate
the mechanisms of cachexia in metastatic kidney cancer and is technically innovative because it uses new
preclinical models, a unique biorepository of human tissues, and cutting-edge approaches. This research is
significant because it will likely provide strong scientific justification for or against new cachexia treatments
targeting metastatic bone disease and the IL-6 pathway. It will also provide a pathway to scientific independence
for a promising early-career orthopaedic-surgeon scientist.

Public health relevance
PROJECT NARRATIVE The impact of cancer-related cachexia on public health is increasing as cancer patients live longer, yet no FDA- approved therapies to reduce cachexia exist today. Recent evidence suggests that metastatic bone disease drives cachexia and this is consistent with preliminary studies in this proposal, which demonstrate cachexia and elevated IL-6 in models of metastatic kidney cancer to bone. The goal of this research project is to explore the scientific rationale and translational potential of therapies directed at metastatic bone disease and IL-6 for the treatment of cancer cachexia.